Molecular Analysis of Bacterial Adaptive Response to Host Reactive Species

Background and Innovation: Diarrheal and invasive infections caused by non-typhoidal Salmonella account
for the highest burden among all foodborne diseases. Non-typhoidal Salmonella infections cause diarrhea in
healthy individuals and are associated with life-threatening disseminated infections in immunocompromised
patients with defects in neutrophils, macrophages, or CD4 T cells due to HIV or cancer comorbidities.
Investigations on the precise activation of virulence programs crucial to Salmonella pathogenesis will lead to
the development of novel antibiotics. Our research has demonstrated that DksA and Gre factors regulate vital
aspects of Salmonella pathogenesis. Specifically, our investigations have uncovered a conserved pocket within
the DksA coiled-coil domain that interacts closely with RNA polymerase and is necessary for the intracellular
lifestyle of Salmonella. A better understanding of the interactions between conserved charged residues in the
DksA pocket will help us improve the design of drugs against this transcription factor. Gre factors compete with
DksA for binding to the secondary channel of RNA polymerase, and like DksA, Gre factors are essential for
Salmonella pathogenesis. We have discovered a hitherto unsuspected, yet essential, link between the
regulatory actions of Gre factors and the activation of Salmonella pathogenicity island-2 (SPI-2) gene
transcription. The Gre-mediated expression of the SPI-2 type III secretion system is likely to play a significant
role in Salmonella pathogenesis, as the horizontally acquired SPI-2 gene cluster is indispensable for
Salmonella’s growth in humans and experimental animal models. Our research aims to elucidate the
biochemical mechanism through which Gre factors activate SPI-2 transcription that is essential for Salmonella
pathogenesis.
Significance and Impact to Veteran’s Healthcare: Acute gastroenteritis associated with non-typhoidal
Salmonella infection is a frequent occurrence among inpatients at VA hospitals. The highest incidence of non-
typhoidal Salmonella cases among veterans and their families is observed in the very young and the elderly.
The emergence of antibiotic resistance poses a significant clinical problem of epic proportions among Gram-
negative rods such as Salmonella. The dwindling number of therapeutic compounds in development
compounds antibiotic resistance. The knowledge gain in our analysis of the conserved DksA pocket will inform
the rational development of future therapies against a variety of Gram-negative, antibiotic-resistant bacteria,
which pose significant risks of morbidity and mortality among active servicemen, women, veterans, and their
families.
Path to translation/implementation: Future prophylactic and therapeutic strategies against drug-resistant
bacteria stand to benefit greatly from the identification of novel molecular targets in pathogenic bacteria. Our
characterization of critical charged residues in the conserved DksA pocket will inform our medicinal chemistry
to improve anti-DksA antibiotics.

Public health relevance
Non-typhoidal Salmonella causes roughly 180 million diarrheal illnesses and over 200,000 deaths yearly worldwide. Immunosuppressed individuals are particularly at risk of suffering life-threatening, systemic non- typhoidal Salmonella infections. Salmonella is among the increasing number of medically important multidrug resistant bacteria that are associated with high morbidity and mortality in veterans and their families. Knowledge of the biochemistry supporting Salmonella pathogenesis will inform the rational development of novel therapies and prophylactic countermeasures. Our investigations have revealed that structurally related DksA and Gre proteins are essential to Salmonella pathogenesis. The proposed investigations will 1) investigate the role of the DksA conserved pocket in transcription of Salmonella virulence genes, and 2) elucidate the biochemical processes by which Gre factors activate Salmonella virulence programs. A deeper knowledge of these unique processes will guide our efforts to develop new classes of antimicrobials.